Developmental Funds-New Investigators

Developmental Funds are a critical component of this CCSG, which are used to shape the future membership of the Kl, to see future research directions within the four Programs, and to ensure that the Center's Core Facilities meet the needs of the membership.